Pain sensitivity and endogenous pain modulation in autistic adults

Project Summary/Abstract
As pain is often the first sign of injury or illness, individual differences in pain perception or communication can
impact diagnosis and treatment of dangerous health conditions. In this proposal, we will investigate differences
in pain perception for autistic adults who may have difficulty communicating about pain due to autism-related
communication difficulties. Emerging evidence suggests autistic adults experience pain differently than non-
autistic adults. Autistic adults report higher pain intensity and more pain-related anxiety compared to non-autistic
adults. Additionally, the pattern of neural responses to pain in autistic adults suggests altered central processing
of pain. However, most of these studies have been conducted in younger autistic adults (<40yrs). This is
concerning as many painful chronic medical conditions become prevalent in mid-adulthood (e.g., back pain,
arthritis, diabetes) and reports suggest autistic adults experience these conditions are an even greater rate,
increasing the potential for disparate pain management in this population. In non-autistic populations, older age
is consistently associated with decreased pain sensitivity. Endogenous modulation of pain in aging is associated
with increased central sensitization (facilitation of pain), and less efficient descending pain modulation (inhibition
of pain). Our preliminary data suggests that autistic adults are affected with persistent pain in adulthood and that
this increases with age. Our conceptual framework suggests that autistic adults may experience persistent pain
in adulthood due to 3 factors: 1) increased pain sensitivity, 2) altered endogenous pain modulation, and 3)
difficulty in pain assessment.
The overall goal of this cross-sectional study is to investigate how pain differs in autistic adults (n=40, ages 30-
70 yrs) compared to age, race, and sex matched non-autistic adults (n=40). To examine how pain perception
may differ for autistic adults, this exploratory R21 will address two targeted knowledge gaps. In Aim 1, we will
use a standard battery of multi-modality (heat and pressure) quantitative sensory testing to address both sensory
and affective pain sensitivity. In Aim 2, we will examine differences in endogenous pain modulatory systems in
autistic adults using both temporal summation (to address pain facilitation) and conditioned pain modulation (to
address pain inhibition). At the end of this study, we will better understand critical differences in pain perception
that may place autistic adults at risk for persistent pain in adulthood. For autistic adults, differences in pain
processing and endogenous pain modulation, coupled with difficulty in social communication and healthcare
access, could lead to poor pain outcomes. The knowledge gained from this study on mechanistic differences in
pain sensitivity and endogenous pain modulation will help build a framework for development of new pain
assessment tools and targeted pain management interventions for autistic adults.

Public health relevance
PROJECT NARRATIVE As we age, accurate pain assessment becomes even more important due to more chronic painful medical conditions and changes in how we experience pain. For autistic adults, communicating about pain may be difficult and result in barriers to adequate pain management and medical care. This project aims to understand how pain may differ for autistic adults to reduce suffering and minimize the effects of mismanaged pain on their lives.